Surgery vs. conservative care for meniscal tear after unsuccessful PT: an RCT

The syndrome of knee pain and meniscal tear is prevalent in persons ≥ 45 years old, and associated with
substantial pain, disability, and cost. Several randomized controlled trials (RCTs) have shown that initiating
physical therapy (PT) in persons with this syndrome is associated with similar levels of pain relief as
performing arthroscopic partial meniscectomy (APM). As a result, initial treatment with PT is now the standard
of care. Those who do not respond to PT are often referred for APM, though there have been no trials of
whether APM is efficacious in this setting.
This planning grant lays groundwork for an RCT to address this important evidence gap. The study team at
Brigham and Women’s Hospital (BWH) and University of Buffalo plans an RCT that enrolls persons with knee
pain, meniscal tear and osteoarthritic changes into a run-in period in which subjects receive a standardized PT-
based regimen. We will identify those with persistent pain despite PT and invite them to be randomized to
either APM or a nonoperative regimen that includes intra-articular injections, an enhanced PT and exercise
program, and additional support provided with web-based, telehealth, and face-to-face encounters with the
research and clinical teams. We will assess pain relief and other outcomes over a two-year period. To prepare
for the RCT, we apply for a planning grant with the following specific aims:
• Finalize the operative and enhanced nonoperative regimen including choice of injection, specific exercise,
and educational and support materials.
• Assess and ensure physician equipoise for the two treatment strategies.
• Estimate the number of eligible subjects/month and conduct model recruitment
• Obtain Single IRB approval with BWH as governing IRB
• Develop key study documents including clinical protocol, manual of operating procedures, safety
monitoring and data monitoring and management plans, statistical analysis plan, recruitment and retention
plan, and training/certification plans
This planning grant will prepare the study team to launch an RCT that has the potential to change practice.

Public health relevance
Knee pain with imaging evidence of meniscal tear is common among middle aged and older persons. The great majority of physicians suggest an initial course of physical therapy for persons with this condition, but there are no studies addressing the best treatment for persons whose pain persists despite PT. This planning grant proposes a range of planning activities to prepare the team to conduct a trial of surgery vs. rigorous nonoperative therapy in persons 45-85 years old with persistent knee pain after PT for meniscal tear.